Leveraging Data for Infants with Cleft to Grow and Flourish: The BLOOM Study

ABSTRACT
Infants with orofacial clefts (‘cleft’) are at high risk of malnutrition. Over 5,000 infants are born with a cleft in the
United States each year. By 3 months of age an estimated 27% of these infants are underweight when
compared to World Health Organization infant growth curves (weight-for-age z-score ≤ -2). The reasons for this
are multifactorial, and involve the anatomical impact of the cleft, lack of timely clinical care with the appropriate
specialists, social determinants of health, lack of access to necessary resources (e.g., cleft bottles, breast
pumps), caregiver factors, and infant health characteristics. We do not know which infants with cleft will
develop undernutrition, which factors are most salient, how undernutrition impacts health outcomes, or how to
prevent undernutrition in this population. The purpose of this project is to address these gaps. We aim to: (1)
Predict which infants with cleft will develop undernutrition and determine associations between undernutrition
and surgical outcomes via a large clinical retrospective cohort study (N~18,000); (2) Quantify associations
between caregiver/infant factors and undernutrition, and quantify relationships between undernutrition and
adverse caregiver/infant outcomes in a prospective cohort study of caregiver/infants (N=336); and (3)
Determine the contribution of caregiver/infant factors to our clinical predictive model for undernutrition. Our
aims complement one another and provide a holistic view of infants with cleft and their experience with
undernutrition and adverse health outcomes. The retrospective cohort study in Aim 1 will leverage curated
electronic health records from PEDSnet, a consortium of U.S. children’s hospitals and a database on over 12
million children with records from 2009 to the present. The prospective cohort study in Aim 2 will include
caregiver/infant dyads and elicit caregiver/infant experiences from birth to 15 months of age. It will focus on
information not in the electronic health record. This prospective cohort study will capture factors related to
caregiver/infant feeding experiences, social determinants of health, frequency of infant infections, caregiver
stress, caregiver quality of life and more. Aim 3 is an exploratory aim in which we will combine data from
PEDSnet with data from our prospective cohort to examine caregiver/infant contributions to our clinical
predictive model developed in Aim 1. Optimal nutrition in early life is a cornerstone of infant health.
Undernutrition in US infants with cleft is unacceptably high and there is insufficient research on how to address
this issue. Our study will address this gap and is responsive to NIH/NIDCR Notice of Special Interest for data
science project in dental and craniofacial research. We will shed light on an under-investigated area in cleft
research and generate a robust, new body of evidence on undernutrition and its impact on adverse health
outcomes in cleft. Our findings will inform the development of a tailored, high impact intervention to ensure
timely growth and health of US infants with cleft.

Public health relevance
PROJECT NARRATIVE Infants with orofacial clefts (‘cleft’) are at high risk of malnutrition in the first months of life, likely due to a host of factors involving the lack of timely care with the appropriate specialists, social determinants of health in the family, source of nutrition (e.g., breastmilk, formula), appropriate resources (e.g., bottles, breast pumps), caregiver factors, and infant health characteristics. This project will develop a predictive model using data from 18,000 US infants to identify infants at high-risk of developing malnutrition and determine the impact of undernutrition on adverse health outcomes including infection, surgical complications, and caregiver stress and reduced quality of life. Our findings will inform the development of tailored, high impact interventions to ensure timely growth and health of US infants with cleft.